TEAD4 and Trophoblast Lineage

DESCRIPTION (provided by applicant): Trophoblast cell lineages build the functional units of the organ, the placenta and are important for the anchorage of the embryo to the mother, for establishing a vascular connection for nutrient and gas transport to the embryo, and expression of hormones that are required for the successful progression of pregnancy. Defective development of the trophoblast cell lineages leads to either failure of embryo implantation or pregnancy associated disorders like preeclampsia. Thus it is important to understand molecular pathways that regulate development of the trophoblast cell lineages. The origination of trophoblast cell lineages starts with the establishment of the trophectoderm (TE), one of the first two cell lineages that are specified during preimplantation mammalian development. Gene knockout studies in mice showed that TEAD4, a member of TEA-domain containing transcription factors, is the master orchestrator of the TE-specific transcriptional program. TEAD4-null embryos do not mature to the blastocyst stage and lack expression of master regulators of trophoblast development, like CDX2, and GATA3. Interestingly, although TEAD4 specifically regulates TE/trophoblast-specific gene expression during early mouse development, direct targets of TEAD4 have not been identified in the TE or in trophoblast progenitors of the developing placenta. Furthermore, functional importance of TEAD4 during trophoblast lineage development after embryo implantation has not been tested. Thus, the molecular mechanisms by which TEAD4 regulates trophoblast lineage development are poorly understood. The goal of this proposal is to define molecular mechanisms by which TEAD4 selectively orchestrate a trophoblast stem cell-specific transcriptional program. Two specific aims are proposed; in aim 1, we will define global TEAD4-dependent transcriptional network in trophoblast cells. Using both mouse and rat as model systems, we will test the hypothesis that TEAD4 regulates a core TSC-specific transcriptional network within the TE of a preimplantation embryo. We will use chromatin immunoprecipitation along with genome wide sequencing (ChIP-Seq) to identify TEAD4 target genes in trophoblast cells and to define a global TEAD4-dependent, trophoblast-specific transcriptional network. In aim 2, we will determine importance of TEAD4 in postimplantation trophoblast lineage development. We will test the hypothesis that similar to preimplantation TE-lineage development, TEAD4 function is also important to maintain expression of TSC-specific genes within the trophoblast progenitors of the developing placenta and impairment of TEAD4 function after embryo implantation will negatively affect development of trophoblast lineages.

Public health relevance
PUBLIC HEALTH RELEVANCE: Defect in the trophectderm and trophoblast lineage development is one of the major causes of early pregnancy loss, which is a major public health concern. In addition, placental development due to impaired trophoblast cell development and functions lead to pregnancies that are at risk for miscarriage and intrauterine growth retardation, and are associated with preeclampsia, a leading cause of maternal death and premature birth. Therefore, understanding the molecular mechanisms of development and function of trophoblast cell lineages is critical to gaining insights into important features of pregnancy loss and pregnancy associated disorders. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Trophoblast cell lineages build the functional units of the placenta [1] and are important for the anchorage of the embryo to the mother to establish a vascular connection for nutrient and gas transport to the embryo, and expression of hormones that are required for the successful progression of pregnancy [2]. Defective development of the trophoblast cell lineages leads to either failure of embryo implantation or pregnancy associated disorders like preeclampsia. Thus it is important to understand molecular pathways that regulate development of the trophoblast cell lineages. The origination of trophoblast cell lineages starts with the establishment of the trophectoderm (TE), one of the first two cell lineages that are specified during preimplantation mammalian development [3-5]. The other earliest lineage is the inner cell mass (ICM), which develops into embryo proper. Studies in rodents indicated that the TE contains a trophoblast stem cell (TSC) population [6], which, after embryo implantation, give rise to multipotent, TSC-like progenitor cells within the extraembryonic ectoderm and ectoplacental cone (EPC) of the developing placenta [7]. Subsequently, those TSC-like progenitors differentiate to other trophoblast subtypes. Studies with gene-knockout mouse models and mouse TE-derived TSC populations (mTSCs) implicated specific transcription factors in establishing the TE/trophoblast-specific gene expression pattern (reviewed in [2, 7]). One of them is TEAD4, a member of TEA-domain containing transcription factors. TEAD4-null mouse embryos do not mature to the blastocyst stage and lack expression of other TE/TSC-specific master regulators like CDX2, GATA3 and EOMES [8-10]. Thus, TEAD4 is considered as the master orchestrator of the TE/TSC-specific transcriptional program in preimplantation embryo. However, it was unknown whether TEAD4 regulates expression of TE/TSC-specific master regulators by directly occupying their chromatin domain or via an indirect mechanism. It was also unknown whether a TEAD4 function is important for the development of TSC-like progenitors in postimplantation embryo. To answer these questions, we begun our study by identifying TEAD4 target genes within mTSCs. We took an unbiased approach, in which we combined quantitative chromatin immunoprecipitation (ChIP) along with deep sequencing (ChIP-Seq) analyses to identify genome-wide TEAD4 targets [11]. Our analyses discovered that a number of TE/TSC-specific master regulators, including CDX2, GATA3 and EOMES, are directly regulated by TEAD4 in mTSCs [11]. We also found that TEAD4 expression is conserved in the TE of blastocysts from several mammalian species including human and is also expressed in TSC-like populations within the mouse EPC as well as in first trimester human placenta. These observations led us to the central hypothesis of this proposal that TEAD4 mediates a conserved function in establishing a TE/TSC-specific transcriptional program across mammalian species. Therefore, using our preliminary studies as a unique foundation, we will identify genes that are directly regulated by TEAD4 within TSCs/TSC-like progenitors from both mouse and rat, and will test whether a common TEAD4-dependent, TSC-specific gene signature could be identified in those cells. In addition, we will also test functional importance of TEAD4 with respect to trophoblast lineage development in postimplantation mouse embryo. Specific aim 1: Defining global TEAD4-dependent transcriptional network in trophoblast cells. We have identified global targets of TEAD4 in mouse TE-derived mTSCs [11]. However, the global targets of TEAD4 in the TE, the primary tissue from which mTSCs were derived, and the TSC-like progenitors within the developing placenta of a postimplantation embryo are still unknown. Also, prior to our study with mTSCs, TEAD4 target genes have not been identified in trophoblast cells. Consequently, TEAD4 targets in TSCs/TSC-like progenitors from other mammalian species are still unknown. Thus, in this aim, using both mouse and rat as model systems, we will test the hypothesis that TEAD4 regulates a core TSC-specific transcriptional network within the TE of a preimplantation embryo as well as in the TSC-like progenitors of a postimplantation embryo. Specific aim 2: To determine importance of TEAD4 in postimplantation trophoblast lineage development. As a TEAD4-null mouse embryo does not mature to the blastocyst stage, functional importance of TEAD4 during postimplantation trophoblast development has never been addressed. Our preliminary studies showed that TEAD4 expression is conserved in TSC-like progenitors of developing mouse and human placenta. Thus, we hypothesize that similar to preimplantation TE-lineage development, TEAD4 function is also important to maintain expression of TSC-specific genes within the trophoblast progenitors of the developing placenta and impairment of TEAD4 function after embryo implantation will negatively affect development of trophoblast lineages. We will test this aim by depleting TEAD4 specifically within the trophoblast cell lineages.